Mechanisms of iNKT cell anti-viral adjuvancy

Summary:
Invariant natural killer T (iNKT) cells have been shown to promote resistance to a variety of viral infections.
Despite their cytopathic-sounding name, it does not seem that the anti-viral effects of iNKT cells are due to
their killing of infected cells. Instead, iNKT cells function as "cellular adjuvants" that promote anti-viral
responses by other lymphocytes, including antigen-specific T cells. iNKT cells are an innate T cell population
that is present in all individuals, and that utilizes a conserved TCR that recognizes lipid "patterns" presented by
non-polymorphic CD1d molecules. As a result of these features, iNKT cells can be targeted in genetically
diverse human populations using a single therapeutic strategy (e.g. anti-TCR antibodies, synthetic lipid
antigens). Thus, iNKT cells could be exploited as a generic (i.e. HLA-independent) strategy to promote anti-
viral antigen-specific T cell responses. The goal of this project is to provide mechanistic data that will support
the development of human iNKT cells as broad anti-viral agents. The mechanisms involved in human iNKT-
mediated adjuvancy in vivo will be investigated using a model of Epstein-Barr virus infection, in which
autologous T cells control the degree of virally-driven B cell hyperplasia. Our preliminary studies show that
administering iNKT cells at late time points after viral infection is associated with clearance of B-
lymphoproliferative masses and with enhanced antigen-specific T cell responses. We will investigate two
specific hypotheses about the mechanisms by which iNKT cells mediate these effects: i) by conditioning of
monocytic APCs in a way that diminishes their immunosuppressive properties and/or enhances their
immunostimulatory features; ii) by directly activating T cells in a way that enables them to overcome
suppressive signals. Aim1 will determine iNKT cell activation requirements; Aim 2 will ascertain the
importance of iNKT cell interactions with monocytic APCs; Aim 3 will assess the impact of iNKT cells on T
cells. These studies will significantly advance our understanding of the cellular and molecular pathways
involved in iNKT-mediated adjuvancy, and will thus guide the development of clinical strategies to engage
iNKT cells to promote anti-viral immunity.

Public health relevance
Narrative: This project will determine how a population of T lymphocytes that is found in all of us promotes immunity to a viral infection. Understanding how these powerful T cells work will help us to develop broad-based strategies to fight viral infections.